Optical Cerebral Hemodynamic Monitoring for the Detection of Large Vessel Occlusion

Endovascular therapy has revolutionized the treatment of acute stroke with large vessel occlusion (LVO) but is
only available at a minority of stroke centers. Prehospital LVO detection provides an opportunity to route patients
to thrombectomy-capable stroke centers and thereby reduce treatment times and improve outcomes. Emergency
medical services (EMS) rely on examination-based stroke severity scales to identify patients with potential LVOs,
but diagnostic accuracy is suboptimal, and implementation has been inconsistent. There is a need for an
inexpensive, easy-to-use, portable instrument that can quickly and reliably detect LVO during prehospital care.
To that end, our group recently validated a novel non-invasive optical imaging modality that leverages principles
of speckle contrast optical spectroscopy to monitor cerebral blood flow (CBF). Innovative features of this optical
technique facilitate high frequency data collection with excellent signal-to-noise, such that morphology of the
CBF waveform can be well characterized. The cortical CBF waveform is particularly abnormal in patients with
LVO, so after consolidating the optical scan into an easy to perform 70-second bedside study, we evaluated 135
patients who presented to the Emergency Department with clinical concern for acute stroke. The optical CBF
waveform data were used to train a deep transformer neural network to recognize waveform features that
discriminated LVO status. This optical classification achieved excellent sensitivity and specificity for LVO
detection and outperformed two commonly used examination-based prehospital stroke severity scales. With this
proposal, we have integrated the optical scan into the acute stroke alert workflow at three Emergency
Departments within Penn Medicine, and we will validate the optical LVO detection algorithm by performing the
70-second optical scan on sequential patients being evaluated for potential acute stroke within 24 hours of onset.
Urgent vascular imaging performed during the stroke alert workflow will provide the gold standard LVO
categorization which will allow us to quantify the diagnostic performance of the optical LVO classification.
Diagnostic performance will be compared with that of currently used prehospital stroke severity scales.
This proposal will all also evaluate the feasibility of portable optical imaging in the prehospital environment
through a collaborative effort with a large EMS provider that works closely with Penn Medicine. Optical
instruments will be installed in several EMS vehicles, and the 70-second optical scan will be integrated into their
prehospital workflow, such that all patients with acute onset focal deficit within 24 hours will be scanned during
the prehospital stroke assessment. Diagnostic performance will be quantified, but this work will primarily be used
to demonstrate feasibility, highlight potential technical challenges in this environment, and reveal opportunities
to streamline workflow.
This proposal provides critical data to spur the translation of optical CBF imaging for portable LVO detection.

Public health relevance
NARRATIVE Early detection of large vessel occlusion (LVO) in patients with suspected stroke facilitates triage to appropriate stroke centers which in turn reduces treatment times and improves outcomes. In current practice, examination- based stroke severity scales are inconsistently used and insufficiently sensitive, so this proposal aims to validate the diagnostic performance of a non-invasive optical blood flow imaging modality that leverages cerebral blood flow waveform data to detect LVO. A previously developed LVO detection algorithm will be validated by a large multicenter sample of patients that present to the Emergency Department with suspected acute stroke, and through collaboration with a large Emergency Medical Services group, feasibility will be explored in the prehospital environment.